Exercise-induced Legacy Health Benefits on Cardiometabolic Risk Factors in Aging Adults with Prediabetes

Abstract
Exercise training produces substantial health benefits, summarized in the Physical Activity Guidelines Advisory
Committee Report and incorporated into the 2008 and 2018 Physical Activity Guidelines for Americans.
Despite the well-known benefits, too few individuals adopt exercise as a health maintenance strategy. Thus,
determining whether a relatively modest duration of exercise training in middle age can lead to sustained
health benefits as individuals progress into older age groups (legacy effects) is of public health and clinical
importance. As the parent R21 seeks to determine whether a relatively short six-month exercise intervention
(STRRIDE-PD) produces sustained, legacy health effects ten years later, this proposed supplement will
simultaneously investigate in a community-based cohort (UNC Alumni Heart Study; UNCAHS) whether self-
directed exercise behavior is also related to long-term health status. Thus, the proposed supplement will
enhance the significance of the parent R21 by extending the generalizability of the findings to individuals who
would not have qualified for the STRRIDE studies due to either their risk factor or medical history status.
Matched to the STRRIDE-PD Reunion cohort, 200 age- and gender-matched participants from the UNCAHS
who have reported on their unsupervised exercise behavior will be invited to complete parallel assessments of
cardiorespiratory fitness and cardiometabolic risk factors. Integrating the UNCAHS via the supplement will
allow us to compare the legacy effects of supervised exercise training programs to self-directed exercise in a
community-based cohort. Taken together, the parent R21 and the proposed supplement will provide unique
insight into the biological and psychological underpinnings of physical activity behavior in midlife and long-term
cardiometabolic health status.

Public health relevance
Project Narrative In medicine, the sustained benefit of a treatment long after cessation of the intervention is termed a legacy effect. As exercise produces substantial health benefits following intervention, this proposal seeks to determine the legacy health benefits of exercise intervention in middle-aged adults and uncover novel pathways by which these exercise-induced legacy health effects occur. This supplementary funded project will extend the findings from the parent project to self-directed community-based settings and home-based exercise routines. Findings from this project will help guide personalized exercise medicine for both short- term clinical needs and long-term health maintenance as individuals age.